Developing a curriculum in obstetric, gynecologic, and reproductive health care equity to bridge research and practice

PROJECT SUMMARY
Structural racism is a fundamental cause of health inequity. There is an urgent need to train health professionals
on structural and social determinants of health, and the role of health care bias in perpetuating and exacerbating
health disparities. Simultaneously, the US maternal health crisis has fueled increasing recognition of curricular
gaps in sexual and reproductive health equity for obstetrics and gynecology (Ob/Gyn) practitioners, and
specifically best practices in research on race, sex, and gender as they relate to quality of care and patient
experience. Initiating this instruction early in medical training and establishing core competencies in unbiased
and antiracist health care practice is critical to cultivating the next generation of clinicians. We aim to develop,
implement, and evaluate a curriculum for medical school learners about the intersection of race, ethnicity, sex,
and gender in Oby/Gyn health care equity. Specifically, we will develop didactic modules on topics including
social and structural determinants of health, gendered racism, intersectionality, reproductive justice, health care
discrimination, and care of gender diverse individuals, with cross-cutting themes of best practices in research,
biologic mechanisms, and interventions (Aim 1). We will create a reflective learning community app to bridge
didactic lectures to clinical clerkships (Aim 2). We will engage community representatives and medical school
learners in co-design of curriculum and app content, including novel integration of narrative and graphic medicine
tools to illustrate patient experiences and lessons for research and clinical care. Finally, we will implement the
curriculum with 140 medical school learners in Ob/Gyn clerkship and elective didactics and evaluate program
objectives through longitudinal learner surveys (Aim 3). At project completion, we will have a portable model for
clinical training programs, using student-led, applied, and reflective learning to bridge research and practice.
This model is responsive to the RFA-OD-22-015 goal to support creative educational activities that develop skills
in multidimensional and intersectional health-related research and healthcare delivery and will fill a critical gap
in physician training, with the expected impact of advancing equity in Ob/Gyn health care quality and outcomes.

Public health relevance
PROJECT NARRATIVE There is an urgent need to train obstetrics and gynecology (Ob/Gyn) health professionals on structural and social determinants of health, and the role of health care bias in perpetuating and exacerbating sexual, reproductive, and maternal health disparities. We will design, implement, and evaluate a curriculum for medical student learners about the intersection of race, ethnicity, sex, and gender in Ob/Gyn health care equity, including didactic modules and a reflective learning community app to provide space for active learning and peer exchange. We will implement the course with 140 medical school learners completing mandatory Ob/Gyn clerkship and elective didactics and conduct longitudinal surveys following the Kirkpatrick model to evaluate learner experience, understanding, ability, and growth.